The effects of wildfire exposure on maternal allergic asthma and consequences on neurobiology

Project Summary/Abstract: Autism spectrum disorders (ASD) are pervasive, highly prevalent lifelong
disorders for which pharmacological interventions are not readily available. While genetic factors are likely
contributors to these disorders, heritability estimates indicate strong environmental contributions. Of particular
interest is the link between fetal gestation and the activation of the maternal immune system during critical
periods of development. Epidemiological reports suggest a strong association between periods of maternal
immune activation and an increased risk of having a child with ASD including immune conditions such as
allergies and asthma. Unique immune cascades representative of asthma and allergy responses have been
detected in amniotic fluid and maternal serum mid pregnancy of mothers whose child was later diagnosed with
ASD. Acute exacerbations are common in pregnant asthmatic women with as many 35% suffering attacks
requiring hospitalization. In addition, particulate matter from air pollution, a major exacerbating factor in allergic
asthma, has been linked with an increased risk for ASD. Wildfire activity, a significant producer of particulate
matter, is increasing in size, severity, frequency, duration of fire season and areas of susceptibility. However,
little is known about the consequences of maternal asthma/allergy mediated responses, wildfire particulate
matter (WPM), or their combined effects on fetal development. We have described the first set of preclinical
studies to test the hypothesis that maternal allergic asthma (MAA) induced during gestation imparts alterations
in brain neurobiology and functional behavioral outcomes in the offspring. We have WPM samples collected in
situ and through proximity sampling of wildfire emissions, capturing the complexity of real-world complex WPM
exposures. We will test the innovative hypothesis that WPM and MAA combined are causally linked to severe
impaired behavioral endpoints that have a high degree of face validity for neurodevelopmental disorders (NDD)
and ASD-relevant symptoms, and that these exposures lead to epigenetic modifications of microglia. The
proposed studies will examine WPM alone and the exacerbating effects of WPM sampled from Northern
California region during fire season and MAA on behavioral outcomes (Aim #1). Pregnancy is a time when
epigenetic changes help a static genome adapt to the maternal environment, so that if the maternal immune
system is overly activated, the fetal immune system will also be over activated at the expense of brain
development. We will test the hypothesis that epigenetic mechanisms control microglia responses in the fetus
following WPM + MAA (Aim #2). If successful, this research will validate the concept that NDD is, for some, a
disorder due to the direct effects of common environmental contaminants on immune mechanisms that will
identify novel mechanisms and preventative strategies for one of the most visible public health concerns of our
time.

Public health relevance
Project narrative: In the last 20 years, rates of diagnoses for autism have increased at an alarming rate, and yet little is understood about its causes and treatment options are limited. By examining two increasingly common risk-related environmental factors – namely asthma and particulate matter of wildfire emissions – we will challenge current paradigms and isolate mechanisms contributing to pathophysiology of autism. This hypothesis-driven integrative study combines immune, complex real-world environmental exposures, epigenetic and behavioral approaches to address a major gap in autism research and will provide critical information on the consequences of environmental contributions to risk for autism, helping to translate epidemiological observation into a functional model that can be utilized for further investigations and identify possible paths for prevention.